Postdoctoral Training in Cardiovascular Clinical Research

The overarching goal of this NRSA application is to provide a high quality, mentored training experience to
develop future thought leaders in cardiovascular clinical research. We will recruit the most promising post-
doctoral cardiology fellows into an optimized clinical research training program that includes: 1) rigorous
didactic training in the methods of clinical research, 2) closely mentored, real world research experience, and
3) structured training and experience in "survival skills" required for a successful academic career. Trainees
will spend at least 2 years in this program and devote 100% effort to the program while they are supported. We
are requesting 6 trainee slots at the post-doctoral level. We have selected mentors for the program from
among the thought leaders in cardiovascular clinical research at Duke. Interdisciplinary co-mentoring will be
required, with each trainee co-mentored by a Duke methodologist. In addition, trainees will be able to select
additional co-mentors from among the excellent faculty participating in this program as well as from among
other Duke faculty, depending on each trainee's needs and research interests. Finally, our program will offer
extramural career and research mentoring from some of cardiology's most respected and renowned leaders at
top academic clinical research programs. For each trainee, several methods will be used to monitor progress,
including the creation of a formal Individual Development Plan that will be reviewed regularly by a Scientific
Oversight Committee and annually by an External Advisory Board. External mentors from among the Advisory
Board will also provide robust assessments of our trainees and our program. Outcomes expected from each
fellow accepted into this T32 program will include scientific presentations at research conferences/symposia
and at national meetings, peer-reviewed publications, an independent research project, and at least one grant
application to support the trainee's post-fellowship research. The Program Directors, faculty, and External
Advisory Committee will assist each graduate in obtaining a faculty position in academics and will further guide
and support them as they transition to independent investigators. The proposed NRSA program will organize
the abundant resources available at Duke for clinical research into a focused and efficient program for training
the cardiovascular clinical research thought leaders of the future.

Public health relevance
The purpose of this grant is to train the next generation of thought leaders in cardiovascular clinical research. These clinical researchers will bring scientific advancements in the care of patients with cardiovascular disease from bench to bedside through large-scale human testing in clinical trials, comparative effectiveness research, patient-centered health services research, outcomes research, and precision medicine research in addition to optimizing systems of care to promote high quality treatment patterns. Trainees supported by this grant are expected to make major scientific contributions to medicine in their academic research careers and have a significant impact on public health.